Georgia's Food and Feed Rapid Response Team Proposal

SUMMRY/BSTRCT Ths pojectwll lowGeogiaoestbisha coordinatdineragncyincidn managmnttamtha encompssesanalha-ardsfoodandfeedemergencyRapidResponse Team(RRT)concept. We wl furtherthisnewresponsecapabilitydbdyngaregonlpepredness componentbyaignngou cpbltesandcombnngthemwthFloid,NothCroianndaT,Vexras'gpneavousefotsto uthe communctionandcolboationefots onaregosnwlelleavesfl, uthe devegloRpRnT resourcetypin with current EMACntativ.eTs hese realSouthenAgicutureandAnmlDsste Rspons (SAADRA) membrsaes. his wll ddelonssga-ermned ofth naionalfoodsafty systembystengthennginteagencycolboaont oen gonlleve. TheGeoga Deprtment ofAgicutue(pGaDAns)towor wit theGeoga Deprtmento Pubic HelthEpdemologySectionandEnvronmentlHelthSections,GEMA,FoodandDugAdmnstation DstictandPogamOfces,therCs oen teDiseseContoanldPrevention,and theGeoriaFusion Cente toaddess TteIIIo theBioteroiTshmeGAecto. gaDeprtment o Agicutuehsstong estbishedcontcts wth ou stteandfedealprtne genceslthstloiwdefwyifnoarmlzed stingunder theRapidResponse Teamconcet The eogaDeprtmentof Agicut'suFeoodSfety Dvsionis curentlyenroledin Mnuactued FoodsReguatoy ProgamStndrdFs (PS). DApanstofolowestbishedtanng,ranedsponse, epotgeneationprogamsas outdibnyeHSEEPBestPactcesandestbished RRTGudncepotocos naddtontoFDACOREBestPactces. TheGeoga Deprtment o , uAngdierceutstuarbelished MemorandumsofUnderstanding, coopraeswihth ubPlicHealth Departmentlaboratoryconductin ood testng. eoga wl utlzNeFt aosaodninformation/communication methodoloy. TheRRT tanngwl stndrdzelaboatoyand smplesubmissonsto maxmzeresponse. Mos,timpotnty thisproject wl utherfciitte theRRTFive Phsesfo food ndfeed totimeyedgdioenlss RT cpbltes.

Public health relevance
Project Narrative Georgia will develop a Food and Feed Rapid Response Team (RRT) in conjunction with the Georgia Department of Public Health, Epidemiology and Environmental Health Sections, the Georgia Fusion Center, the Centers for Disease Control and Prevention, the US Food and Drug Administration, and Academia to more effectively address public health in food and feed emergency events. We will also work cooperatively with four existing RRTs, Florida, North Carolina, Texas, and Virginia, to develop The Regional Investigative Form and collaboratively develop RRT Resource Typing to assist with EMAC (Emergency Management Assistance Compact) capabilities. __SpecificAimsTextDelimiter__ Specific Aims-Georgia Food & Feed RRT Goals of Proposed Project v Implement a Georgia Food and Feed Rapid Response Team in Georgia v Develop a Regional Response capability through mentoring with four regionally established RRTs: Florida, North Carolina, Texas and Virginia v Develop a Regional Investigation Form Summary of Expected Outcomes v Hire a RRT Program Manager and an Epidemiologist v Coordinate with US Food & Drug Administration, Georgia Public Health and Georgia Department of Agriculture on selection of Command and Core response team members v Finalize Georgia's Food Emergency Response Plan v Collaboratively develop the Georgia Food and Feed RRT SOP v Collaboratively develop Georgia's RRT Communication Plan to include the creation and approval of a notification Protocol, including notification methodology v Develop and deliver training for State Agencies, FDA staff, and Regional RRT mentors related to the implementation of the Georgia Food and Feed RRT and regional response capabilities v Mentorship Trainings v Develop RRT Resource Typing Guidance v Implementation of the Regional Investigation Form v Develop an Incorporation Plan and Timeline v Develop a Georgia Food and Feed Improvement Plan v FREEB Wilted Woes TTX and After-Action Review v State and Regional Lab Exercise and After-Action Review v Regional EMAC Exercise and After-Action Review v Annual Summary Reports v Demonstrate successful implementation of Georgia Food & Feed RRT through Capabilities Assessment Result of Proposed Project Developing a Georgia Food and Feed RRT will allow for increased communications between state and federal partner agencies and provide a systematic food and feed response capability in Georgia. The work with regional RRT mentors will create a consistent and strong regional Food and Feed Response Team capability that will build upon established best practices and create a cooperative regional capability that can be shared on the national level through trainings and further collaborations with other states. The development of RRT Resource Typing Guidance documents will contribute to the national food preparedness system, and the development of the Regional Investigation Form will create an additional investigative tool for the RRT Toolkit.